Optimizing Cell Therapy to Counter Adaptive Resistance Mechanisms in Prostate Cancer

2/34"4& $".$&2 *3 4)& -/34 '2&15&.4,9 %*"(./3&% $".$&2 '/2 -&. *. 4)& .*4&% 4"4&3 ".% ! $".$&2 0"4*&.43
".% *3 4)& 3&$/.% ,"2(&34 $"53& /' $".$&2 2&,"4&% %&"4) *. -&. %6".$&% 02/34"4& $".$&2 7)*$) %&6&,/03 *.
/' ",, 02/34"4& $".$&2 0"4*&.43 *3 490*$",,9 #/.& -&4"34"4*$ ".% 2&3*34".4 4/ ".%2/(&. %&02*6"4*/. 4)&2"09
)& 2&,"4*6& 9&"2 3526*6", 2"4& '/2 0"4*&.43 7*4) "%6".$&% 02/34"4& $".$&2 *3 ".% 4)& -&%*". /6&2",,
3526*6", 2".(&3 #&47&&. -/.4)3 )&2&'/2& ./6&, 42&"4-&.4 /04*/.3 "2& .&&%&% '/2 0"4*&.43 7*4) "%6".$&%
02/34"4& $".$&2 %/04*6& 42".3'&2 /' ,9-0)/$94&3 &.(*.&&2&% 4/ &802&33 $)*-&2*$ ".4*(&. 2&$&04/23 3
*3 " ./6&, 4)&2"0&54*$ -/%",*49 4)"4 )"3 (&.&2"4&% 5.02&$&%&.4&% 2&30/.3&3 *. 0"4*&.43 7*4) )*(),9 2&'2"$4/29
$&,, ,&5+&-*" ".% ,9-0)/-" ".% -5,4*0,& -9&,/-" ".% )/,%3 02/-*3& "3 " 0/4&.4*", 42&"4-&.4
'/2 02/34"4& $".$&2 . " 2&$&.4 0)"3& 42*", )"*,&% "3 " $,*.*$", -*,&34/.& *. 02/34"4& $".$&2 0"4*&.43 7&2&
42&"4&% 7*4) "54/,/(/53 30&$*'*$ $&,,3 "2-/2&% 7*4) " %/-*.".4 .&("4*6& β 2&$&04/2 /52
0"4*&.43 "$)*&6&% " ; 2&%5$4*/. *. ".% 4)& '"*,52& /' 4)& $&,, 4)&2"09 7"3 "$$/-0".*&% #9 ".
"%"04*6& 2&30/.3& *. 4)& 45-/2 -*$2/&.6*2/.-&.4 4)"4 ,&% 4/ 502&(5,"4*/. /' -5,4*0,& ,/$",*:&% *.)*#*4/29
-/,&$5,&3 )& $&.42", )90/4)&3*3 /' 4)*3 02/0/3", *3 4)"4 "%"04*6& 2&3*34".$& 54*,*:&3 -5,4*0,& -&$)".*3-3 4/
&3$"0& 3526&*,,".$& ".% "44"$+ '2/- 4)& *--5.& 3934&- 4)&2&'/2& *--5.& $&,,3 &.(*.&&2&% 7*4) -5,4*02/.(&%
"002/"$)&3 4/ 4"2(&4 4)& 45-/2 4)& ".% /6&2$/-& "%"04*6& 2&3*34".$& -&$)".*3-3 7*,, 02&6&.4
$&,, '"*,52& ".% 45-/2 &3$"0& . 02*/2 345%*&3 $&,, 4)&2"0*&3 4"2(&4*.( (,9$/'/2-3 /' -5$*. ".%
'*#2/.&$4*. 0/34 42".3,"4*/.",,9 -/%*'*&% 7*4) 4)& . ".4*(&. " 425.$"4&% (,9$". %&-/.342"4&% 45-/2 30&$*'*$
"$4*6*49 "("*.34 02/34"4& $".$&2 *. 8&./(2"'4 -/%&,3 ".% " 2&%5$4*/. *. 45-/2 -&4"34"3&3 )&3& 345%*&3
*%&.4*'*&% ,/33 /' *.4&2'&2/. ("--" 3*(.",*.( "3 ". "%"04*6& 2&3*34".$& -&$)".*3- 4)"4 %&3&.3*4*:&3 45-/2 $&,,3
4/ $&,, -&%*"4&% $94/4/8*$*49 ".% "(/.*343 /' 3*(.",*.( 4)"4 *.%5$&% ". *.4&2'&2/. ,*+& (&.& 3*(."452&
39.&2(*:&% 7*4) $&,,3 4/ /6&2$/-& 4)*3 2&3*34".$& -&$)".*3- )& 2"4*/.",& '/2 4)*3 2&3&"2$) *3 4)"4
*%&.4*'*$"4*/. /' $/5.4&2 2&3*34".$& -&$)".*3-3 4)"4 -"*.4"*. $&,, "$4*6*49 *. 4)& $/.4&84 /' "%"04*6&
2&3*34".$& #9 02/34"4& 45-/23 )& $&.42", )90/4)&3*3 /' 4)*3 02/0/3", 7*,, #& 4&34&% #9 05235*.( 4)2&&
*.%&0&.%&.4 30&$*'*$ "*-3 4/ %&3*(. %5", 4"2(&4*.( $&,,3 ".% 342"4&(*&3 4/ -/%5,"4& 4"2(&4 ".4*(&.
&802&33*/. 4/ 02&6&.4 45-/2 &3$"0& 4/ *%&.4*'9 -&$)".*3-3 /' $&,, ".% "(/.*34 39.&2(9 *. 02/34"4&
45-/23 %&'*$*&.4 *. *.4&2'&2/. ("--" 3*(.",*.( 4/ &.)".$& $&,, 2&3*34".$& 4/ *--5.& $)&$+0/*.4 ".%
*--5./35002&33*6& $94/+*.&3 )*3 2&3&"2$) 7*,, &.)".$& 4)& %&04) /' 5.%&234".%*.( /. 4)& -&$)".*3-3 /'
45-/2 &3$"0& 4)2/5() "%"04*6& 2&3*34".$& "3 7&,, "3 4)& #2&"%4) /' *--5./&.(*.&&2*.( 342"4&(*&3 ".%
4)&2"0&54*$ /04*/.3 *. 4)& 0*0&,*.& /' 0/4&.4*", 02/34"4& $".$&2 42&"4-&.43

Public health relevance
Prostate cancer accounts for nearly one-third of all cancer diagnoses amongst men in the VA patient population, and a percentage of prostate cancer patients will develop bone metastatic cancers, which remain incurable. Current standard-of-care treatment options for bone-metastatic prostate cancer improve overall survival by a modest four months, highlighting a need for more efficacious therapies. Adoptive transfer of engineered immune cells has led to decade-long remissions in adult and pediatric patients with B cell leukemia and a phase I clinical trial of engineered immune cells in patients with metastatic castrate-resistant prostate cancer (mCRPC) demonstrated feasibility and promise. In the proposed research, we aim to develop engineered immune cells capable of overcoming adaptive resistance mechanisms of prostate cancer, including targeting multiple antigens simultaneously, negating immunosuppressive signaling, and synergizing orthogonal mechanisms of immune engagement and cytolysis to improve treatment options for veterans with prostate cancer.